Columbia Collaborative HIV/AIDS Clinical Trials Unit

The Columbia Collaborative HIV/AIDS Clinical Trials Unit (Columbia Collaborative CTU) brings
together a dedicated and cohesive group of investigators and two institutions situated in New York
City (NYC), one of the epicenters of the US epidemic. This collaboration includes highly
experienced investigators and two successful clinical research sites (CRSs) with breadth and depth
of expertise in clinical, translational and behavioral HIV research to be responsive to the rapidly
evolving research needs in HIV prevention (including passive immunization with single,
combination of multiple or multi-specific broadly neutralizing monoclonal antibodies, vaccines,
novel antiretroviral-based approaches, and integrated biomedical and socio-behavioral strategies)
and HIV therapeutics (including antibodies and long-acting antiretroviral formulations, and
antiretroviral-free approaches to remission, biobehavioral interventions to improve adherence and
reduce the risk of treatment failure, in addition to tuberculosis, complications and comorbidities), as
defined by the Division of AIDS (DAIDS) Clinical Trials Networks (CTNs).

Public health relevance
PROJECT NARRATIVE Despite great progress in HIV prevention and treatment, many questions remain to be addressed. The Columbia Collaborative HIV/AIDS Clinical Trials Unit is located in a hot spot of HIV activity and is perfectly positioned to conduct cutting edge clinical trials and contribute to scientific agendas of the DAIDS-sponsored Clinical Trials Networks.